Ben Archer Health Center Internet Connection Project

DESCRIPTION (provided by applicant): The objectives of this project are: A) Installation of an Internet connection where none now exists in Columbus and Alamogordo, Ben Archer Health Center satellites; and B) Broadening access within Ben Archer Health Center Hatch, Truth or Consequences and Las Cruces sites whose existing Internet connection has limited access. The aims of this project are: 1) The purchase and installation of equipment and services for the connectivity to the Internet; 2) Training will be provided to all users; and 3) Internet Connections will be made widely available to all appropriate personnel.